CRISPR detection of circulating cell-free Mycobacterium avium complex (MAC) DNA for rapid diagnosis and monitoring of MAC pulmonary disease

PROJECT SUMMARY/ABSTRACT
Nontuberculous mycobacteria (NTM) are opportunistic environmental pathogens that are present in soil and
water. NTMpulmonary infections, most commonly due to Mycobacterium avium complex (MAC), may result in
chronic, debilitating pulmonary disease (MAC-PD). Treatment, when necessary, consists of 3-4 antibiotics for
14+ months. MAC-PD disproportionately impacts the elderly and women, and those with underlying lung
diseases. The prevalence of MAC-PD is increasing, a trend that will likely continue due to aging populations and
increased comorbidities. Our lack of disease biomarkers poses significant diagnostic and therapeutic challenges.
In contrast with its well-studied cousin tuberculosis (TB), with NTM it is difficult to discern colonization vs. disease
caused by these organisms and determine when treatment is necessary or successful. For many patients it is
difficult to obtain sufficient respiratory sputum samples to culture for diagnosis or to monitor for microbiologic
response during therapy. There is a critical need for non-invasive biomarkers to monitor disease activity and
treatment response, in order to limit sputum induction or bronchoscopy procedures and exposure to computed
tomography scan radiation. Furthermore, treatment is frequently initiated to improve the patient's symptoms but
there is scant data on the correlation of measures of patient-reported outcomes with biomarkers of MAC-PD.
The Hu lab has developed an ultra-sensitive CRISPR diagnostic assay using a portable CRISPR-based test to
rapidly detect TB cell-free DNA (cfDNA) directly from blood samples. The test allows early TB diagnosis and
precisely quantifies TB cfDNA for rapid assessment of disease severity or anti-mycobacterial treatment efficacy.
We have preliminary data to suggest this approach can be applied to MAC-PD; accordingly, we seek to evaluate
a cfDNA CRISPR-based diagnostic assay (CRISPR-NTM) to diagnose MAC-PD and measure treatment
response. We will conduct Aims 1 and 2, analytical and clinical validation of the CRISPR-NTM in patients with
MAC-PD during Years 1-2. Aim 2 will use established NTM Biobanks associated with our NTM Clinical Trial
Network (OHSU Coordinating Center) to identify a retrospective cohort of patients with MAC-PD and uninfected
controls with and without chronic underlying lung disease. During Years 1-4, for Aim 3, we will further utilize our
NTM Clinical Trial Network to prospectively collect longitudinal blood samples from patients starting treatment
for MAC-PD (NTM-TREAT) from our 1) ongoing pragmatic clinical trial (MAC2v3) and 2) non-MAC2v3 clinic
patients representing a broader “real-world” patient population. We will also enroll a pilot cohort at treatment
completion (NTM-TRACK), who are subsequently monitored for microbiologic relapse/re-infection. During Years
3-5 we will complete Aim 3 to evaluate the potential for CRISPR-NTM to monitor microbiologic treatment
response and relapse/re-infection. Ultimately, the identification of a biomarker for pulmonary MAC-PD and other
clinically relevant NTM species will optimize diagnosis and monitoring, and facilitate therapeutic decision-making.

Public health relevance
PROJECT NARRATIVE Chronic Mycobacterium avium complex (MAC) pulmonary disease is an increasingly common orphan disease that causes progressive disability in older adults and has a tremendous unmet therapeutic need. We seek to conduct analytic and clinical validation of a CRISPR-based blood test for MAC cell-free DNA as a measure of MAC pulmonary disease activity and treatment response. This biomarker could ultimately be used to guide diagnostic and therapeutic decision-making with regard to MAC pulmonary disease.